Molecular Mechanisms of Cell Cycle Control

ABSTRACT
Regulated progression through the cell cycle is essential for normal development and to prevent uncontrolled
proliferation that can lead to cancer. The focus of my laboratory is to understand the molecular mechanisms that
control cell growth and division, with the goal of understanding how mutations in the cell cycle-regulatory network
contribute to disease. To accomplish this, we take molecular and systems level approaches in budding yeast to
gain mechanistic insights into cell cycle regulation, and later to probe the conservation of these mechanisms in
human cells. The current proposal focuses on two key unanswered questions. First, how does multisite
phosphorylation regulate protein function to drive cell cycle progression? Cyclin dependent kinases (CDKs)
phosphorylate hundreds of proteins to orchestrate the cell cycle, but how they regulate most substrates is not
known. We recently developed a high-throughput approach that can dissect multisite phosphorylated domains
to discern the contributions of each individual site to the regulation of protein function. We will use this approach
to investigate how CDK regulates its protein substrates and to determine how multisite phosphorylation impacts
the activities of human transcription factors to drive proliferation. Second, is cell cycle regulation important for
cells to adapt and survive in stressful environments? Cells transiently arrest the cell cycle when they are exposed
to environmental stress, and after they adapt to the stressor the cell cycle resumes at a slower rate. We will
elucidate the mechanisms that control adaptation to chronic stress and investigate the importance of cell cycle
regulation for adaptation and survival. Stress responses not only ensure that healthy cells can survive in
challenging environments, but they also contribute to disease by enabling cells to survive where they shouldn't
and providing resistance to therapies. Our findings may suggest strategies to disrupt adaptation in disease
contexts. In addition, this project will uncover conserved mechanisms that control proliferation, potentially offering
targets for intervention in cancer cells.

Public health relevance
PROJECT NARRATIVE Regulated progression through the cell cycle is important to limit cell growth and division. Loss of these controls can lead to unrestrained proliferation and the development of cancer. The goal of this project is to understand the pathways that control the cell cycle, to identify strategies for inhibiting the proliferation of cancer cells.